Esophageal gland-mediated immune evasion by the human parasite Schistosoma mansoni

PROJECT SUMMARY/ABSTRACT
Despite the hostile environment of the bloodstream where the host immune system is highly active, schistosomes,
parasitic flatworms that cause schistosomiasis that affects over 200 million individuals globally, have a
remarkable ability to thrive inside the vasculature for over several decades. While the tegument (outer skin) has
been shown to play an important role in parasite immune evasion, what remains a mystery is the mechanism by
which parasites neutralize large amounts of immune components that they ingest from the host blood. Our
recently published work reveals that the esophageal gland, an anterior accessory organ of parasite's digestive
tract, is essential for schistosomes to survive inside the bloodstream. It operates by lysing ingested immune cells
before passing them into the gut, preventing them from accessing the inner parasite tissues. Such observations
lead us to hypothesize that specific esophageal gland proteins block and/or degrade host immune components,
thereby ensuring parasite survival. The main questions that we are interested in are: What are the roles of
esophageal gland factors in degrading and/or blocking host immune components and how do such functions
contribute to parasite survival? What is the mechanism of specific esophageal gland factors in parasite immune
evasion? These will be investigated under three specific aims: 1) Define the esophageal gland cell types and
genes; 2) Determine the role of specific esophageal gland factors in immune cell lysis and parasite survival; and
3) Determine the mechanism of specific esophageal gland factors in host-parasite interaction. In the first aim,
we will systematically identify esophageal gland genes by comparing RNA-seq data between parasites with and
without the esophageal gland tissue. In the second aim, we will functionally interrogate identified genes using
RNAi coupled with an in vitro feeding assay, and determine the viability of candidate gene-deficient parasites
inside the mammalian host. Preliminary results from these aims reveal dozens of esophageal gland factors, two
of which appear to be essential for degrading host immune cells. Thus, in the third aim, we will determine the
activity of the two candidate proteins, identify their binding partners, and decipher the mechanism of host-parasite
interaction. Together, we expect to bring new insights to schistosomes' esophageal gland-mediated immune
evasion mechanism by identifying essential esophageal gland factors and their mode of action. The proposed
study is innovative since our findings will likely shift the paradigm of schistosome immune evasion, which has
been thought to be driven primarily by its tegument. Our study is significant since it bridges parasite
developmental and translational biology by identifying essential esophageal gland molecules and understanding
how they operate. These candidates may be exploited in the future as potential therapeutic targets that can
complement praziquantel in its limitations and collectively contribute to the fight against schistosomiasis.

Public health relevance
PROJECT NARRATIVE (Parent Grant) The proposed research is relevant to public health since it focuses on understanding the immune evasion mechanism deployed by the human pathogen Schistosoma mansoni. Completion of the proposed study will bring new insights to how schistosomes operate inside the human host and identify potential targets for future therapeutic design that could aid in combating schistosomiasis.